Mwanza-Tanzania Research Training Program in HIV Clinical Investigation

The program will strengthen patient-oriented HIV clinical investigation training of physician-scientists and
other exceptional clinicians in Mwanza, in northwestern Tanzania. The program builds upon two decades of
collaboration and capacity building by the partner institutions. The primary research institution in Tanzania will
be the Mwanza Intervention Trials Unit (MITU), which is a unit of Tanzania’s National Institute for Medical
Research (NIMR). MITU was established in 2006 as a collaboration between NIMR and the London School
of Hygiene and Tropical Medicine (LSHTM) to strengthen HIV interventional research in Tanzania. MITU
collaborates closely with the Weill Bugando School of Medicine, which is also located in Mwanza. Weill
Bugando was established in 2003 to train physicians for northwestern Tanzania. MITU and Weill Bugando
have collaborated with Weill Cornell Medical College since their founding.
This research training program aims to fill a critical gap in Mwanza: the need for Tanzanian physicians with
rigorous training in patient-oriented HIV clinical investigation. We use the NIH definition of clinical
investigation as research which directly interacts with individual patients or clusters of patients in Phase I, II, or
III clinical trials, pragmatic trials, or formative epidemiologic or behavioral research in preparation for clinical
trials. The goals of the proposed training program are: 1.To increase the number of clinical investigators at
MITU and thereby increase institutional capacity for HIV clinical investigation 2. Establish Weill Bugando/MITU
as a sustainable training center for HIV clinical investigation. The ultimate goal is to prevent new HIV
infections, provide effective HIV care, and improve HIV outcomes in Tanzania and East Africa.
We will provide long-term training to fifteen outstanding clinician scientists to conduct patient-oriented HIV
clinical investigation. We will primarily train physicians but will also train exceptional other clinicians (PharmD,
DMD). We will train 10 PhDs, and 5 MS degree candidates. Tanzanian trainees will benefit from participation
in 17 active research projects in five synergistic areas of HIV investigation including HIV prevention and
vaccine research, implementation of HIV testing and treatment, women’s health, HIV related co-infections, and
HIV and cardiovascular disease. We will also strengthen the PhD program in clinical investigation at Weill
Bugando by introducing 4 new graduate courses in clinical investigation. Weill Cornell is committing
institutional funds so that 4 of the best PhD graduates can have 2-year post-doctoral appointments as
MITU research scientists after their Fogarty training. At the end of the 5-year training program, MITU will have
a cadre of clinical investigators and a greater depth and breadth of externally funded HIV patient-oriented
research. MITU/Weill Bugando will be a training hub for HIV clinical investigators in East Africa.

Public health relevance
PROJECT NARRATIVE The objective of this training program is to increase the number of Tanzania physician scientists with rigorous training in patient-oriented HIV clinical investigation. Mwanza Intervention Trials Unit (MITU) and Weill Bugando will establish courses in clinical investigation, advanced biostatistics, and epidemiology to be offered in Mwanza and 15 long-term trainees will conduct mentored research in one of the following HIV research priority areas: HIV prevention and vaccine research, implementation of HIV testing and treatment, women’s health, and management of HIV related opportunistic infections and cardiovascular disease. The goal is to establish MITU/Weill Bugando as a training hub for HIV clinical investigation in East Africa.